Evaluation of the influence of angiotensin type 1 receptor expression under disease conditions in an autoimmune cystitis animal model

PROJECT SUMMARY
IC/BPS is challenging to diagnose as the symptoms overlap with other bladder diseases, making the condition
often misdiagnosed. Symptoms include lack of infection, frequent urination, increased residual urine volume,
painful intercourse, chronic pelvic pain, and an increased urge to urinate. Fundamental knowledge gaps exist in
our understanding of what causes IC/BPS; however, a recent theory suggests (angiotensin II) Ang-II signaling
may play a role in bladder disease pathology as there are similarities between IC/BPS and other organ tissues
where Ang-II signaling is well established. For example, in the lungs, heart, liver, and kidney, one of the Ang-II
receptors, angiotensin receptor 1a (AT1R), is upregulated with tissue inflammation and fibrosis. However, the
functional role AT1R plays in bladder pathophysiology is unknown. Preliminary data using our AT1aR-tdTomato
mouse line show that AT1R mRNA and protein are expressed in both the urothelium and the detrusor smooth
muscle from naïve animals. Furthermore, the AT1aR-tdTomato area of fluorescence increases in our acute
cystitis mouse model, suggesting an increase in AT1R-expressing cells following inflammatory tissue insult.
Based on preliminary data, I propose to investigate if Ang-II signaling contributes to pathological changes in the
bladder in a chronic bladder inflammatory mouse model. It is challenging to represent IC/BPS with one single
animal model; therefore, it is worth further investigating the chronic experimental autoimmune cystitis (EAC)
where I will specifically examine AT1R expression. In aim 1, I hypothesize that bladder AT1R expression
increases in an EAC mouse model that can be attenuated with inhibition of mast cell activity. I will utilize our
AT1aR-tdTomato mouse line for the EAC model. Then, I will utilize RNA-sequencing, RNAscope in situ
hybridization, western blot, and immunohistochemistry to evaluate AT1R expression in naïve, vehicle, and EAC
bladder tissue. In aim 2, I hypothesize that AT1R knocked out of the urothelial cells will reduce bladder
inflammation, mast cell infiltration, pelvic hypersensitivity, and micturition frequency in an EAC mouse model. I
will utilize a UPK2cre-AT1aR knock-out mouse line to determine the influence of urothelial AT1R on EAC
symptoms. I will use behavioral assays to assess pelvic sensitivity and urinary function. Additionally, I will use
biochemical and histological analyses to quantify inflammatory cytokines and AT1R expression. Collectively, the
goal of this proposal is to determine the role of local Ang-II signaling in chronic bladder disease pathophysiology
to aid in the development of more effective treatments.

Public health relevance
PROJECT NARRATIVE Interstitial cystitis/bladder pain syndrome (IC/BPS) is a chronic, painful urinary disease condition that affects about 4-12 million Americans. IC/BPS has no cure, and treatments are generally ineffective and invasive, greatly decreasing patient quality of life. Investigating signaling pathways activated by chronic bladder inflammation will enhance our understanding of bladder disease pathophysiology and could provide the potential for new, less invasive treatment options to improve patient quality of life.